Implementing a Guidelines-Based M-Health Intervention for High Risk Asthma Patients

Project Summary
Adolescents with asthma are at increased risk of adverse health outcomes related to asthma and are a group that is
traditionally difficult to engage in self-management strategies for chronic illnesses. Smartphone use is prevalent and has
been cited as a preferred method of communication among adolescents. The overall goal of the proposed project is to
examine the effectiveness of a personalized, interactive asthma smartphone application in reducing asthma morbidity
among adolescents who are at increased risk for future asthma exacerbations. Further, we will examine the impact of
sharing smartphone asthma-related data with the primary care provider (PCP) on outcomes. To address this goal, we
propose to conduct a 3-arm randomized, controlled trial with 432 at risk adolescents, ages 12-20 years, with uncontrolled,
persistent asthma, to test the effectiveness of a mHealth Asthma Action Plan (mAAP) application that provides real-time,
personalized feedback, asthma education, and data logging/tracking capabilities with and without PCP data sharing. The 3
groups will include: 1) a group utilizing the mAAP alone, 2) a group utilizing the mAAP with PCP data sharing (mAAP-
DS), and 3) a usual care (UC) group that will utilize a smartphone application with daily non-asthma-related reminders
(attention control).
We will examine the application’s effectiveness compared to UC. The UC group will receive a simple mobile health
application that will deliver daily reminders to eat fruits and vegetables via push notification. With the proposed mAAP,
adolescents with asthma will have an individualized AAP readily available in a socially acceptable format (smartphone
application) and will have the capability of utilizing the application at any time to guide asthma self-management. The
mAAP will not only provide recommendations for steps to take during acute symptoms but will also reinforce daily
medication adherence by sending medication and prescription refill reminders and reinforce asthma self-monitoring by
sending prompts to record routine peak flow measurements and/or asthma symptoms. Further, data derived from the
mAAP will be shared with participants in the mAAP-DS group and will allow investigators to measure the impact of data
sharing on outcomes. We hypothesize that the mAAP will be an effective tool to reduce asthma-related morbidity among
adolescents. This novel approach has high impact potential as it may be applicable to other age groups and patients with
other chronic medical conditions.

Public health relevance
Narrative Guidelines-based asthma care has significantly and consistently proven to improve asthma outcomes, yet guidelines-based care has not fully translated to the community. This is particularly problematic for high-risk populations such as adolescents. The proposed project promotes guidelines-based asthma self-management and encourages medication adherence in a manner that fits with societal trends and preferences of today's adolescents through a smartphone-based platform. Should the project prove successful in reducing morbidity and improving the health of adolescent children with asthma, it has the potential to serve as a model for improved asthma care in other high-risk populations and for other chronic diseases.